Research Training in Integration of Epidemiology and Implementation Science for Neglected Zoonotic Disease Control in Peru

Research Training in Integration of Epidemiology and Implementation
Science for Neglected Zoonotic Disease Control in Peru
PROJECT SUMMARY
The mission of this D43 application is to develop and establish an innovative transdisciplinary
training program in implementation science and epidemiology for Neglected Zoonotic Disease (NZD)
control in Peru. NZDs affect mainly the poor and have devastating effects on the affected individuals
and their families and communities. Due to migration and travel, high-income countries and their
health systems are also affected by NZDs. Despite NZDs impact and importance, there are no formal
training programs to allow professionals to focus on these diseases in Peru. This D43 application is a
collaboration between Universidad Peruana Cayetano Heredia, the leading biomedical institution in
Peru; the Perelman School of Medicine at the University of Pennsylvania, a world-renowned
academic health institution; and the Tulane School of Public Health and Tropical Medicine, a global
powerhouse for tropical infectious disease training, with additional input from experts from other
institutions in the US and overseas. It proposes to prioritize training for young scientists from
disadvantaged areas in Peru, leveraging existing related infectious disease and implementation
science programs, while capitalizing on the extensive network and reach of collaborating institutions
and research hubs across various regions. This network includes a stellar group of faculty with
diverse research projects. The Principal Investigators’ distinctive set of skills: a clinical epidemiologist,
a veterinary epidemiologist, and an implementation scientist, make them a perfect “One Health” team
to train scientists to tackle zoonotic diseases in Peru and Latin America.
Throughout the 5-year grant period we propose to: a) train 8 Peruvian students per year (40
total) in the Diploma of Operational Research and Implementation Science; b) train 4 Peruvian
students per year (20 total) in the Master’s in Control of Infectious and Tropical Diseases; c) train 2
Peruvian scientists between years 2-5 (8 total) in the Penn Summer Implementation Science Institute;
and our ultimate goal, d) train 5 Peruvian students in PhD programs in Peru and the US.
Focusing on coursework and hands-on experiences in implementation science and
epidemiology of NZDs will provide our trainees with new tools and perspectives to improve
interventions, conduct well-designed studies, and build policies and programs to reduce NZDs and, in
turn, reduce inequalities in health. As former Fogarty trainees ourselves, we will apply the FIC
philosophy to build local individual research capacity and move us toward the WHO goal of ending
neglected tropical diseases.

Public health relevance
Research Training in Integration of Epidemiology and Implementation Science for Neglected Zoonotic Disease Control in Peru NARRATIVE Neglected Zoonotic Diseases (NZDs) disproportionately affect poor communities, are still frequent in most of the world, and have a catastrophic impact on the affected individuals and their families. Even though NZDs are frequently introduced into high-income countries representing a significant cost for their health systems, this group of diseases does not represent an important market for pharma and does not attract the same attention as emerging diseases, resulting in few training programs devoted to their study. This D43 application will develop and establish an innovative training program in implementation science applied to NZDs in Peru that is focused on selecting trainees from underserved areas, leveraging existing coursework, providing networking opportunities and hands-on training through identified research projects related to implementation science and NZDs, and applying our training philosophy to build a new cadre of young, committed, and talented researchers to get us closer to the targets established by the WHO Road Map for ending Neglected Tropical Diseases.